Administrative Supplement - Rapid Actionable Data for Opioid Response in Kentucky (RADOR-KY)

Abstract
Systematic and algorithmic biases in machine learning (ML) modeling and underlying definitions
for capturing opioid overdose may result in inaccuracies in burden measures for disparate groups,
potentially leading to an ineffective and unequal distribution of harm reduction and prevention
resources. Identifying and evaluating data and model biases and health disparities is critical to
effective public health practice and research. This project is a supplement to RADOR-KY (Rapid
Actionable Data for Opioid Response in Kentucky; 1-R01 DA057605-01). The RADOR-KY project
will build a robust state-wide surveillance system for opioid use disorder (OUD) including opioid
overdose, integrating multiple data sources to monitor and predict drug overdose mortality and
morbidity. The system will be used by stakeholders to inform data-driven action, supporting the
coordination and targeting of prevention and treatment efforts. As proposed in the parent grant
for this supplement, the RADOR-KY system will integrate several data sources, including
Emergency Medical Services (EMS) data, to develop machine learning predictive models and
forecasting for opioid overdoses to inform public health and public safety agencies’ actions and
planning. The proposed administrative supplement of RADR-KY will improve our understanding
of the ethical aspects of these machine learning/artificial intelligence methods. EMS run data for
opioid overdose surveillance is a promising new system that overcomes limitations of traditional
data sources, such as prolonged delays and omission of non-clinical overdose events. While
recent national standards have improved the structural components of EMS encounter data, the
quality and completeness of such data still necessitate reliance on patient care narratives for case
assertion. There have been a host of opioid overdose definitions proposed, typically focused on
keyword matches or other rule-based criteria, with little emphasis on definition validation,
comparative evaluations, or demographic parity. Critically, no previous models, whether machine
learning or rule-based, have considered demographic fairness in their approaches. Leveraging
our access to over 3.5 million EMS detailed encounter records access under RADOR-KY’s data
use agreement, along with expert-labeled and extracted data, we aim to assess these proposed
models against our own machine learning natural language processing classifier, particularly
considering disparate populations. The specific aims are to 1) Evaluate potential bias in the opioid
overdose data and definitions and identify suitable definitions for each specific sub-population;
and 2) Identify, address, and generate bias-aware ML-ready datasets.

Public health relevance
Project Narrative Emergency Medical Services (EMS) run data for opioid overdose surveillance is a promising new system that overcomes limita�ons of tradi�onal data sources, such as prolonged delays and omission of non- clinical overdose events. There have been a host of proposed opioid overdose machine learning or rule- based EMS deﬁni�ons and models, but none of them have considered demographic fairness in their approaches. Leveraging our access to over 3.5 million EMS detailed encounter records access under RADOR-KY’s data use agreement, along with expert-labeled and extracted data, we aim to assess these proposed models against our own machine learning natural language processing classiﬁer, par�cularly considering performance and fairness for disparate popula�ons.